Structural Robustness of Ribosome Functional Centers

Project Summary
The ribosome is the macromolecular machine, conserved throughout evolution, that is
responsible for the synthesis of proteins and is therefore a fundamental component of gene
expression. Because of its central role in biochemistry, the ribosome has become the target of
more than half of all antibiotics, and the evolution of antibiotic resistance due to mutations in the
ribosome has become a major threat to human health. Understanding the molecular basis of
antibiotic resistance therefore has significant implications for the fight against the threat of
resistance. In deciphering the mechanism of antibiotic resistance, fundamental insights into the
mechanism of ribosome function can also be acquired, leading to possible novel antimicrobial
agents through rational drug design. Through an ongoing collaborative effort, this proposal
capitalizes on the ability of the PIs to combine genetics and structural biology to address
fundamental questions of ribosome structure and function and provide a framework for future
development of novel antimicrobial agents. The Aims of this proposal are: (1) Dissect 30S subunit
conformational dynamics during tRNA movement through the ribosome; (2) Define the role of two
intersubunit bridges in 30S-50S rotation during translocation; (3) Determine the structural basis
for signaling pathways through the ribosome.
Achieving these aims will involve exploiting the expertise of the three PIs to generate and
characterize functionally impactful mutants and determine their structures by X-ray
crystallography or cryo-electron microscopy. The strengths of our proposal include: (1) extensive
expertise in the experimental methods to be applied; (2) a long track record of effective
collaboration between the PIs; (3) an extensive publication track record in the field of ribosome
structure and function; (4) a large volume of preliminary data and ongoing studies, including
multiple studies nearing completion. Accomplishing these goals will significantly advance the field
by answering long-standing questions about antibiotic resistance mechanisms, while
simultaneously expanding our understanding of the basic underlying mechanism of the ribosome.

Public health relevance
Project Narrative The ribosome is the macromolecular machine responsible for protein synthesis and deciphering its structure-function relationships is a fundamental biological problem. We will use a combination of genetics, molecular biology, and structural biology approaches to address basic questions of ribosome structural dynamics as they relate to function. The ribosome is also the target of more than half of all antibiotics, and a deeper understanding of the molecular mechanism of antibiotic resistance is an immediate outcome of this work.